Core A

Core A (Administrative Core): ABSTRACT
Core A (Administrative Core) is a large core that comprises sub-groups for administrative leadership, scientific
and educational leadership, database and bioresource organization, and public education and outreach. For an
efficient and central operation of the overall Center, we have integrated these distinct components under the
leadership of Core A PI, who also serves as the Center Director. Accordingly, this Core has four major aims as
follows: In Aim 1, we will provide centralized administrative leadership for the entire Center grant. In Aim 2, we
will provide centralized scientific and educational leadership for the entire Center grant. Scientific leadership
includes assistance and guidance to the Center members on three overarching scientific questions for the
Center (questions on animal-human translation, olfactory epithelium (OE) pathology, and study design that can
be linked to future validation of the discoveries from the present proposal). This Core will also facilitate and
moderate scientific collaboration with investigators outside the Center. In addition, we will provide a
“multidisciplinary” educational platform for young scholars in the Center, which includes the arrangement of
periodic group meetings and an annual retreat. Scientific rigor and integrity, as well as, an individual
development plan for each scholar will be emphasized. Furthermore, this Core will facilitate communications
with the institutional leadership and the advisory board members, and lead a preregistration of the proposed
study to the Center of Open Science. In Aim 3, we will organize bioresources and datasets, building a useful
database. The goal of this Aim is to store, organize, and keep track of datasets and resources collected in this
P50. Accordingly, we will provide the Center investigators with quick access to well-documented and
standardized databases. This central data management will improve the efficiency of the collaborations among
Projects and Cores and help to resolve confusion or conflicts. In addition, this also facilitates future data
sharing with peers and the public. Finally, in Aim 4, we will lead public education and outreach for our peers
and the general public. The overall Center will emphasize the significance of public education and outreach to
our peers and society. Accordingly, this Core will generate and maintain the web page of the P50 Conte
center, organize education and outreach plans, including the maintenance and expansion of the programs that
we have established during the past P50, such as the Schizophrenia Center Annual Symposium, Monthly
Seminar Series, Mind the Gap Workshop, and family meetings where the Center-associated physicians meet
with patients and their family members in a panel format. We believe that this Core will play a key role by
providing a central service in administrative leadership, scientific and educational leadership, database and
bioresource organization, and public education and outreach. This Core will lead research rigor and integrity. In
sum, this Core will aim to organize the Center and provide meaningful deliverables to our peers and society.